Evaluating the effect of a new Medicare dental benefit on the health of older adults

PROJECT SUMMARY
This is the Paul B. Beeson Emerging Leaders Career Development Award in Aging submission for Lisa Simon,
MD DMD, an internal medicine physician, general dentist, and early-stage investigator whose work focuses on
the impact of oral health access on health outcomes for older adults. Through this Career Development Award,
she will strengthen her skills in advanced analytic techniques and mixed methods analysis and develop clinical
expertise in the medical and dental care of older adults. Although oral health is an important component of
overall health for older adults, Medicare has not historically offered a dental benefit. Through a policy change
beginning in 2023, traditional Medicare has begun covering dental services for Medicare beneficiaries with
certain eligible diagnoses: those undergoing organ transplant, cardiac surgery/valvuloplasty, those with head
and neck cancer, and those with cancer receiving chemotherapy, intravenous bisphosphonates, or chimeric
antigen receptor T-cell therapy. This policy change represents a novel opportunity to evaluate the effect of
dental access on both the dental and medical outcomes of Medicare beneficiaries through the following
specific aims, leveraging both advanced methods that support causal inference and qualitative analysis: 1) to
determine the change in rates of dental visits and complete tooth loss among Medicare beneficiaries with
conditions meeting eligibility for the new dental benefit; 2) to evaluate treatment effect heterogeneity of dental
coverage for eligible Medicare beneficiaries by racial and ethnic identity, geography, and availability of dental
care; and 3) to identify the barriers and facilitators associated with Medicare enrollment among dentists. In
tandem, with the support of an exceptional mentorship team, Dr. Simon will pursue the following career
development goals to enrich her research and leadership abilities. These goals are: 1) to develop expertise in
geriatric medicine at the interface of medicine and dentistry to better understand the health needs of older
adults; 2) to acquire advanced skills in data science methods including causal inference and claims data
analysis; and 3) to develop proficiency in qualitative research and its application to aging policy. Brigham and
Women's Hospital and Harvard Medical School are the ideal environment for research excellence, with a
strong background in Medicare policy evaluation and advocacy for older adults. Upon completion of this Career
Development Award, Dr. Simon will be uniquely equipped to achieve independence as a researcher in aging.

Public health relevance
PROJECT NARRATIVE This project will evaluate the impact of Medicare's new limited dental benefit on healthcare utilization and outcomes for older adults, a population with significant unmet oral health need. By identifying disparities in access to care and understanding the barriers to Medicare participation among dentists, the research will provide critical evidence to inform policy decisions aimed at expanding dental coverage for all Medicare beneficiaries. Ultimately, this work seeks to improve oral health and overall health outcomes for older Americans, contributing to healthier aging.